Systems-wide analysis of oxidative stress-responsive m6A epitranscriptome

PROJECT SUMMARY/ABSTRACT
The recent emergence of the epitranscriptomics field has opened the possibility to understand and manipulate
a previously underappreciated regulatory layer involved in biological processes. In particular, our research
focuses on m6A as a candidate of interest given that it is the most prevalent RNA modification in the nervous
system that controls multiple aspects of RNA metabolism. We have previously shown the critical roles of m6A
regulation in axonal plasticity and synaptic activity. This proposal extends our research scope and focuses on
how the m6A epitranscriptome responds to environmental perturbation using innovative methods for the
identification of biomarkers and molecular pathways linked to adverse outcomes. We will use system-wide
approaches to address the following questions: (i) What is the mechanism to remodel the m6A epitranscriptome
upon toxicant exposure, (ii) How do the dynamics of m6A reshape the transcriptome? (iii) What are the
characteristics of mis-localized RNA that are associated with disease state and risk? We expect that our
proposed study will significantly advance our understanding of how epitranscriptomic regulatory processes
constitute key pathogenic mechanisms following environmental challenges. Data gained from our systematic
profiling and functional validation may offer new opportunities for developing diagnostics and/or biomarkers to
facilitate the development of more effective prevention and treatment strategies for these diseases.

Public health relevance
PROJECT NARRATIVE Elucidating the action of m6A remodeling complex and the resulting m6A epitranscriptome will reveal how the m6A machinery is dysregulated by environmental exposures. This will ultimately aid in the design of effective diagnostics and facilitate prevention and treatment strategies for exposure-associated disease development.